Just Inclusion and Equity: Negotiating Community-Research Partnerships in Genomics Research (JUSTICE)

PROJECT SUMMARY
Centering justice in bioethics is critical to promoting research on the ethical and equitable development and
deployment of emerging biotechnologies. Building capacity for more effective and relevant bioethics
requires not only engagement with multidisciplinary scholarship but also scholars historically
underrepresented in bioethics and in other disciplines and adjacent fields. Few mechanisms exist for
supporting sustained and substantive dialogue on justice and applying frameworks to real-world efforts in
the development and deployment of biotechnologies. This project addresses this gap by creating a
mechanism for trainees across disciplines to engage ethical frameworks that focus on justice and equity,
and to develop an academic network in bioethics. Our proposal aims to build capacity in bioethics research
through sustained and systematic multidisciplinary explorations, dialogues, and the development of
educational materials on justice frameworks. To achieve these objectives, we have two objectives: 1) to
create a hybrid series “Justice Dialogues” a virtual monthly series that will feature speakers whose
scholarship focuses on justice theories and frameworks, and convene scholars from disciplines beyond
bioethics, such as science, technology and society studies, gender and ethnic studies to engage theories
and frameworks of justice and their applications in research of the development and deployment of
biotechnologies, including in genomics, AI, and precision medicine; and 2) to develop and disseminate
educational resources to train scholars and scientists to engage research questions of justice in the ethical
and equitable development and deployment of emerging biotechnologies through a publicly accessible
website dedicated to disseminating recordings of didactic presentations, synchronous group discussions,
curated literature collections and other related resources.

Public health relevance
PROJECT NARRATIVE This project aims to build capacity in bioethics through sustained and systematic multidisciplinary explorations of frameworks of justice and their applications to bioethics research on the ethical and equitable development and deployment of biotechnologies, including in genomics, AI and precision medicine. We will create a hybrid series Justice Dialogues and related educational resources to support justice-forward bioethics research and researchers.